Administrative Supplement: Improving AI/ML-Readiness of data generated from HALBE or other NIH-funded research

PROJECT SUMMARY Currently, data collected and shared in the biorepository of our parent project HABLE continues to expand rapidly. Artificial Intelligence and Machine Learning (AI/ML) cannot make these data valuable to biomedical research until these data are AI/ML-ready. Therefore, there is an urgent need to develop effective AI/ML readiness for HABLE and other NIH-funded data-sharing projects. This proposal will focus on three critical and common areas to improve the AI/ML-readiness of data generated from our parent HABLE project: missing data imputation, feature selection and outlier removal, and data readiness report. We will address the following three specific aims: Aim 1) Develop a Machine Learning Based Multiple Imputation Method for Handling Missing Data; Aim 2) Develop a Recursive Feature Elimination and Cross-Validation (RFE-CV) Algorithm for Feature Selection and Outlier removal, and Aim 3) Develop an Integrated Tool to Report Data Readiness. The algorithms and tools from this application will be the first of their kind to report data readiness for NIH data- sharing projects to facilitate heterogeneous data and feature engineering for AI/ML. It will make data scientists improve their AI/ML modeling more effectively and effortlessly. The administrative supplement project will benefit not only the parent HABLE project but also all other NIH-funded data-sharing projects. We expect that with the development of the algorithms and tools we will complete high data readiness in the HABLE project, which will eventually make HABLE more innovative in developing state of the art methods for Alzheimer’s Disease (AD) clinical trials, leading to the development of effective personalized treatments which slow the progression of, and prevent, AD.

Public health relevance
PROJECT NARRATIVE Effective AI/ML readiness is critical for data mining, modeling, and prediction in HABLE and other NIH-funded data-sharing projects. This research project will develop algorithms and tools to improve the AI/ML-readiness of data generated from NIH-funded research from three areas: missing data imputation, feature selection and outlier removal, and data readiness report. The algorithms and tools proposed herein will make the AI/ML endeavors of data scientists more efficient, productive, and successful.